Brain aging and Alzheimer's related dementias: convergence onto retrotransposons and endogenous retroviruses

PROJECT ABSTRACT
This proposal investigates the mechanisms by which aging impacts the risks of
Alzheimer’s and related dementias (ADRD). The central hypothesis of this proposal is
that age and neurodegenerative protein pathology synergize to activate
retrotransposons and endogenous retroviruses. The proposed work will test the idea
that age impacts the risk of ADRD onset, and that retrotransposons impact the rate of
decline. These mobile elements cause DNA damage, leading to non-cell autonomous
toxicity of glia to nearby neurons. The proposed work will systematically vary
aging/longevity in the context of models of ADRD, and test the impacts as measured by
the toxicity of retrotransposons and endogenous retroviruses. Direct readouts of the
health and lifespan of the animals will be correlated with retrotransposon expression and
replication, and functional manipulations will be used as well.

Public health relevance
PROJECT NARRATIVE This proposal investigates the effects of aging on risk of neurodegenerative disorders, and the hypothesis that aging and neurodegeneration synergize to activate retrotransposons and endogenous retroviruses, which are virus like elements that reside in the genome. The proposal makes use of well established Drosophila models of neurodegeneration that are relevant to Alzheimer’s Related Dementias, and well established pathways to modulate the lifespan. The proposal will test the interactions between aging and neurodegeneration using readouts of effects on retrotransposons, endogenous retroviruses as well as impacts on cell death, DNA damage, and organismal health and lifespan.